PROCUREMENT OF ADDITIONAL IT SERVICES TO ASSIST IN INSTALLING AND TESTING OF THE LICENSE INSTALLATIONS OF SEVEN HOSPITALS IN NY STATE.

PROCUREMENT OF ADDITIONAL IT SERVICES TO ASSIST IN INSTALLING AND TESTING OF THE LICENSE INSTALLATIONS OF SEVEN HOSPITALS IN NY STATE.